Optimizing adherence to the treatment of sleep apnea among patients with strokeundergoing inpatient rehabilitation

Project Summary/Abstract:
The burden of stroke remains unacceptably high and few treatments are proven to improve stroke prevention
or recovery. An estimated 70% to 90% of stroke survivors have obstructive sleep apnea (OSA). Compared to
those without OSA, stroke patients with OSA have worse functional outcomes after inpatient rehabilitation
(IPR), 40% longer IPR stays, a 100% increase in the risk of non-fatal cardiovascular events, particularly
recurrent stroke, and a 75% increase in the risk of early death. Observational data suggest that treatment with
continuous positive airway pressure (CPAP), the first-line treatment for OSA, holds promise to improve stroke
outcomes, including both preventing recurrence and improving recovery. However, poor CPAP adherence has
compromised pilot trials of stroke survivors with OSA, yielding mixed results and limiting the ability to test
CPAP efficacy. Individualized behavioral interventions to improve CPAP adherence have shown benefit in the
general population, though little is known about their effectiveness to optimize CPAP among stroke patients,
who are likely to respond to behavioral interventions differently. We propose to adapt and refine for stroke
patients a multicomponent behavioral intervention to improve CPAP adherence with the engagement and input
of stroke survivors. Then, within a multicenter randomized controlled trial, we will test the efficacy of the
intervention, initiated during inpatient rehabilitation, on CPAP use among stroke patients over the course of 3
months. The adherence intervention will include: 1) CPAP technical support, 2) motivational enhancement
therapy, and 3) self-monitoring using mobile health technologies with automated support. If successful, the
study will provide researchers a much-needed intervention to realize the full benefits of CPAP after stroke. It is
difficult to imagine a non-invasive, relatively low-cost intervention with a similar potential as CPAP for such a
common and disabling a disease as stroke.

Public health relevance
Project Narrative Continuous positive airway pressure (CPAP) for the treatment of obstructive sleep apnea (OSA), an under- recognized but common disorder after stroke, holds promise to improve stroke outcomes but is severely limited by poor post-stroke adherence. We propose to adapt and refine a multicomponent CPAP adherence intervention for stroke patients and then test it among stroke patients. Optimization of CPAP use among stroke patients will allow for the conduct of rigorous clinical trials of OSA treatment after stroke and ultimately to advance the care of stroke patients.